Immunomodulation of the Tumor Microenvironment with Molecular Targeted Radiotherapy to Facilitate an Adaptive Anti-Tumor Immune Response to Combined Modality Immunotherapies

ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-21-083. In our Cancer Moonshot IOTN U01 award, we are developing a combined modality therapeutic
approach to eradicating metastatic cancers that are immunologically “cold” and do not respond to immune
checkpoint inhibition (ICI). To advance the objectives of that award and to broadly define the radiosensitivity
and immuno-radiobiology of immune cell lineages, we will use advanced immune assays to determine the
effects of radiation dose, dose rate, and fractionation on the survival and phenotype of immune cell lineages
from blood, bone marrow, and tumor infiltrating immune cells. We hypothesize that diverse immunologic effects
of radiation will have distinct dose-response profiles, such that no single dose of radiotherapy can be defined
as “optimal” but rather that a heterogeneous dose of radiation will be best able to activate a potent anti-tumor
immune response by optimally engaging distinct mechanisms within a single tumor microenvironment. The
insights and treatment regimens developed in these studies should enable more effective clinical
translation of therapeutic approaches that combine radiation and immunotherapies in patients with
metastatic cancer.

Public health relevance
PROJECT NARRATIVE We aim to identify mechanisms to optimize the potential synergies of radiotherapy with immunotherapy for the management of solid tumors. In our parent U01 award we are pursuing this using combinations of low dose targeted radionuclide therapy and higher dose external beam radiation therapy. In this NOT-CA-21-083 Supplement, we propose to specifically define the radiation sensitivity of immune cell lineages in vitro and in vivo from circulating, bone marrow, and tumor-infiltrating immune cell populations.